NIDDK National Research Service Award (NRSA) T32 Diversity Administrative Supplement

PROJECT SUMMARY
This application seeks renewal of a long-standing, innovative and highly successful postdoctoral
training program in Nutrition that has a primary goal of training the next generation of physician scientists
and PhD researchers committed to disease prevention and health promotion through careers in
Nutrition. As suboptimal diets have surpassed tobacco smoking as the leading global mortality risk
factor, the rationale for an outstanding nutrition research workforce is compelling. The training
program, based in a major academic medical center, addresses 3 broad themes: 1) obesity and its co-
morbidities; 2) nutrition, diet and eating behavior; and 3) lifecourse and development. Faculty mentors
include a balanced mix of MD (10) and PhD (14) researchers representing 5 academic units in the
university, and whose nationally recognized research spans basic (T1) to translational (T4) approaches. All
faculty are affiliated with the NIH-supported Colorado Clinical and Translational Sciences Institute,
which offers excellent support for translational research and numerous training and career
development programs. Trainees to date typically have been physicians (1 position) seeking a career in
academic medicine and nutrition-related research and PhD’s (2 positions) pursuing postdoctoral training in
one of our thematic areas. The specific objectives of the training program include achieving excellence in
all aspects of the scientific literature and methods relevant to trainees’ areas of research, with an
emphasis on understanding scientific rigor and reproducibility and guiding principles of ethical conduct
in research; mastering basic principles of Nutrition Science; preparing and submitting research grants
and manuscripts; and acquiring skills for professional development and communication to undertake a
successful academic career. The program provides 2-3 yr of research training, which includes
ongoing rigorous work with a primary mentor, and interaction with faculty leadership and all trainees
supported by this T32 plus other pre- and postdoctoral trainees through participation in weekly
Nutrition Journal Club, professional development series and Nutrition seminar series. Of recent past
trainees, two-thirds have obtained grant funding, and 80% have progressed to careers in academic
settings. Based on increases in the quality and number of applicants, including physicians, relative to
number of available slots, we propose an additional position for the next cycle, thus projecting 2 MD
and 2 PhD trainees. The training environment promotes collaborative research and fosters
productive interaction between physicians and PhD researchers, a model that prepares trainees to
be exceptionally well positioned to emerge as future leaders in Nutrition to address the most compelling
global health challenges.

Public health relevance
NARRATIVE The research training provided by this program will accelerate the development of a new generation of physician-scientists and to post-doctoral fellows in multidisciplinary research areas related to the field of Human Nutrition. The program provides outstanding training in the setting of an academic medical center. All fellows will be poised to launch successful independent research careers in translational Nutrition science, from bench to bedside to community, and to be leaders in disease prevention and health promotion across the life cycle.